RAPID ACCELERATION OF DIAGNOSTICS ( RADX) PROGRAM: TECH PROJECT #2322 MICROGEM (MICROLAB)

A battery powered, POC/at home device for the quantitation and detection of SARS-CoV-2 simultaneously with Influenza A & B, with the accuracy, specificity and sensitivity equivalent to or better than the current CDC RT-PCR Lab based methodology.